Single Cell Analysis of the Infiltrative Margins of Glioblastoma and Post Treatment Recurrence

PROJECT SUMMARY

Glioblastoma (GBM) is a deadly form of malignant glioma against which conventional targeted therapies and
immunotherapies have had limited success. Both intratumoral heterogeneity and the complexities of drug
delivery in the brain are formidable challenges in neuro-­oncology, while the “immune cold” nature of these tumors
poses challenges to immunotherapy. We recently discovered that acute tissue slices of human GBM surgical
specimens recapitulate the detailed cellular and molecular features of glioma tissue and that, when combined
with single-­cell RNA-­seq, can be used to identify cellular subpopulations that are sensitive to a given drug. These
models are particularly notable for their preservation of the immune microenvironment and quiescent GBM cell
populations. We propose to use this acute slice model to 1) identify the targetable cellular phenotypes and
differential drug responses in the core and infiltrative margins of GBM by comparing the effects of cytotoxic drugs
that preferentially target proliferating glioma cells (the topoisomerase inhibitors etoposide and topotecan) and
quiescent glioma cells (the ferroptopsis inducing drug RSL3), alone and in combination, 2) determine the effects
of combining ferroptosis-­inducing therapy with immune-­modulatory treatments with a STING agonist (cyclic
dinucleotide) using slices generated from the core and margins of GBM. We will also test these drugs and drug
combinations in immunocompetent orthotopic glioma mouse models and orthotopic xenografts of patient derived
glioma cells to assess the effects on glioma progression and survival.

Public health relevance
PROJECT NARRATIVE Glioblastoma is a form of malignant brain tumor with poor prognosis. The tumor cells are highly heterogeneous and involve a complex microenvironment that includes both neoplastic and non- neoplastic brain cells. In this proposal, we use acute tissue slices generated from patient- derived brain tumor samples and orthotopic mouse models that recapitulate the cellular features of these complex tumors, combined with single- cell analysis, to determine the effects of drugs and drug combinations that target specific subpopulations of cells in the tumors and surrounding brain.